Administrative Supplement to Harnessing Alkyl Amines and Alkyl Alcohols in Cross-Coupling

ABSTRACT
This supplement to R35 GM131816 is directed towards the purchase of a Shimadzu Nexera™ Ultra High
Performance Liquid Chromatograph (UHPLC) for the efficient determination of enantiomeric excess of organic
compounds. Because of the differing biological activities of enantiomers, efficient methods are required to
prepare bioactive molecules in high enantiomeric purity. Recognizing this important need, the development of
new methods to prepare highly enantioenriched organic compounds is a major focus of the parent research
program. The proposed UHPLC instrument will replace a rapidly deteriorating 14-year-old HPLC, which has
been a critical workhorse instrument to enable the R35-supported research.

Public health relevance
The search for new medicines requires the discovery of new molecules, and the increasing awareness that saturated atoms correlate to successful drug development mandates that these molecules be three- dimensional. The proposed research program is relevant to public health, because it will enable efficient access to three-dimensional molecules from widely available precursors. The ultimate goal of this research is to facilitate the discovery of new molecules for the study and treatment of human disease.